Doctoral and Post-doctoral Training in Craniofacial Biology

The future of dental education and support for biomedical research require investment in the selection and
training of tomorrow's scientists, including basic, translational and clinical researchers. One of the stated goals
of the NIDCR is to “ensure that a diverse network of highly trained scientists is available in appropriate
scientific disciplines to address the Nation's biomedical, behavioral, and clinical research needs”. In an effort to
achieve this goal, we are seeking renewal of our NIDCR-sponsored Institutional Training Program in Oral
Health Research, which provides an array of training opportunities in craniofacial health research. This grant
thus requests support to provide education and intensive, integrated research training for a select cadre of
scholars seeking either a PhD degree or postdoctoral training (for both DDS/MD and PhD graduates) with a
major focus on dental, oral and craniofacial health and disease. Only the most highly qualified and motivated
predoctoral and postdoctoral candidates will be selected for T90/R90 support. The T90 and R90 award
components will allow us to continue to train U.S. citizens and permanent residents as well as non-permanent
residents, who bring a global perspective. International scholars, clinician-scientists and underrepresented
minorities have made, and will continue to make, significant contributions to dental and craniofacial research
and teaching, serving as outstanding role models. We will continue to emphasize selection of qualified,
exceptional candidates from underrepresented backgrounds to further enhance diversity in the biomedical
workplace. At a time when inclusion and understanding have never been more important, fostering a diverse
cohort of academic researchers is a core component of our mission to prepare this next generation of leaders.
Outstanding predoctoral and postdoctoral trainees will be interviewed and chosen by an Internal Steering
Committee (ISC) for an initial 12-month period of support, and provided they demonstrate satisfactory
progress, will be awarded support for another 12 months. Program oversight will be from the Principal
Investigator and Co-Investigator, the ISC, and an advisory External Steering Committee (ESC). Trainee
mentors will be primarily tenured faculty from either the Herman Ostrow School of Dentistry (Ostrow) or the
Keck School of Medicine (Keck) of USC. Mentors have been selected using two simple criteria: 1) they
maintain active research profiles and have a significant history of successful mentorship, and/or 2) they have
current independent research funding from the NIDCR, which serves as a strong indication that their research
interests are in alignment with the stated goals of the NIDCR. During the T90/R90 appointment period trainees
will enroll in grant writing classes, attend seminars and workshops, and submit a competitive peer-reviewed
grant application. Both Ostrow and the Provost's Office at USC remain fully committed to this and similar
federally supported NRSA training grants, and will ensure that additional financial support is in place to achieve
all stated outcomes.

Public health relevance
The goal of this training grant is to educate a cadre of outstanding scholars seeking either a PhD degree or postdoctoral training (for both DDS/MD and PhD graduates) to pursue basic, fundamental, translational, or clinical research and prepare for careers relevant to dental and craniofacial disease and health. We recognize the significant contributions of international scientists, clinician-scientists and underrepresented minorities to dental and craniofacial research, mentoring, and teaching; and, we strive to appoint trainees with very diverse research experiences, background and education. Our aim is to develop a diverse cohort of independent scientists who will have a significant impact on the dental, oral and craniofacial health-related research needs of the nation, and the world.